Landis Award for Outstanding Mentorship

Project summary
Nervous system injury can have devastating long-term effects on brain or nerve function, yet signaling pathways that
regulate nervous system responses to injury, especially in early acute phases, remain poorly defined. In our previous work
we sought to identify molecules required to drive axon degeneration after axotomy and identified dSarm/Sarm1 as a key
signaling molecule that drives axon auto-destruction. In dsarm/Sarm1 null mutant flies or mice, severed distal axons do
not degenerate and remain morphologically intact for weeks after injury. Understanding how dSarm/Sarm1 signals in
axons is now a major focus for the field, but the vast majority of studies have focused on the final outcome of axotomy—
axonal degeneration—which occurs many hours to days after axotomy. In preliminary work we discovered that nerve
injury leads to rapid changes (within 2-3 hrs after injury) in axon transport in both severed axons and adjacent intact
neurons, and a suppression of sensory signal transduction in intact neurons throughout the nerve. We wish to understand
how injury signals spread throughout the nerve so quickly to activate these response (which we refer to as Phase 1
responses), and the roles that neurons and glia play in this process. Interestingly, we found that components of the dSarm
signaling pathway, the Ca2+-driven Unc-76àCacophonyàCamK-IIàdSarm signaling pathway, and components of the
MAPK pathway play important roles within 3 hrs after injury to alter axonal cell biology and function. In addition, we
found that the glial receptor Draper/MEGF10, functions in glia to activate Phase 1 responses in intact neurons (but not
severed neurons) within 3 hrs after injury. In Aim 1 we will characterize this novel role for dSarm/Sarm1 and the axon
death signaling machinery in regulation of early (Phase 1) responses in intact neurons and severed axons in a simple,
genetically-tractable injured nerved, and how these signaling events alter neurophysiology. In Aim 2 we will perform
similar studies to explore a novel role for the Unc-76àCacophonyàCamK-IIàdSarm signaling pathway and MAPK
signaling in axonal Phase 1 responses to nerve injury. In Aim 3 we will determine how nerve injury severity regulates
neuronal and glial responses to injury, and how the Draper signaling pathway helps spread injury signals along a nerve to
modulate nerve-wide changes in axon physiology. This work will provide important new insights into how axon death
signaling molecules regulate acute responses to nerve injury, identify new molecules involved in injury signaling (Unc-76,
Cacophony, CamK-II), clarify how MAPK signaling drives changes in axon biology after injury, and delineate exciting
new roles for Draper/MEGF10 during the acute window of nerve responses to injury. Given that dSarm/Sarm1 and
Draper/MEGF10 signaling pathways (and their functional roles) are highly conserved, our work will illuminate
fundamental mechanisms of nervous system injury signaling that should have high relevance to human neural injury and
neurological disease.

Public health relevance
Project narrative Nervous system injury or disease results in the degeneration of neuronal fibers, connections in the brain are lost, and neural function is irreversibly compromised. How tissues and cells in the brain communicate with one another after injury to mediate these responses remains poorly defined, but we discovered a remarkable group of molecules that potently suppress many of the negative effects associated with brain after injury. The work in this proposal will define precisely how these molecules function to coordinate nervous system responses to injury, and should lead to the identification of exciting new candidates for therapeutic intervention in neurological disease.